Achieving Model Fairness on Automatic Primary Open-angle Glaucoma Screening

Project summary/abstract
In the United States, primary open-angle glaucoma (POAG) is the leading cause of blindness, especially
among African and Hispanic Americans. Because visual function loss from POAG is irreversible, it is critical to
estimate the risk of POAG and prevent further vision loss. Recently, there has been growing concern that the
predictive model may reflect and amplify human bias and reduce the quality of their performance if used in the
clinical pipeline for patient triage. Motivated by known differences in disease manifestation in patients such as
sex and race/ethnicity, this study hypothesizes that algorithms trained on existing datasets will exhibit systematic
biases in subpopulations. Popular approaches to remove such biases suggested that having a greater number
of positive cases across demographics helped models perform better in validation. However, collecting new data
often suffers from a lack of demographic representation. In response to NOT-EY-22-004 (Research Addressing
Eye and Vision Health Equity/Health Disparities) and PAR-22-141 (Secondary Analysis of Existing Datasets),
this project will develop and validate a new artificial intelligence approach to improve the fairness of the predictive
model on POAG risk estimation without the need for demographically balanced datasets. Based on our
preliminary data and our experience with an interdisciplinary team of data scientists and ophthalmologists, we
plan to execute specific aims: 1) studying “algorithmic bias” in the POAG risk estimation and 2) examining the
impact of “transfer bias” from the biased to the demographically balanced data. The studies proposed in this
project are novel and innovative because the secondary analyses of existing data provide additional insight into
POAG health disparities. Aim 1 will be the first to perform a systematic study of algorithm bias in the DL-based
POAG predictive models and identify the factors contributing to model fairness. Aim 2 will be the first study to
examine that bias transfer may arise in the POAG prediction setting and can occur even when the POAG dataset
is explicitly de-biased. We argue that our models provide simple, interpretable, and easily checkable frameworks
to allow better POAG risk estimation for protected groups. The expected outcome of this project is a holistic
framework to mitigate the impacts of inequity by improving the inference performance for minorities. The success
of this project will provide additional insight into health disparities of POAG risk estimation by (1) reducing clinical
decisions tainted by unconscious or conscious bias, and (2) developing brand-new models that reflect learned
POAG features but not patient demographic to ensure robustness across diverse populations. This project is
highly feasible and potentially transformative for both data science and clinical medicine.

Public health relevance
Project narrative The proposed research is relevant to public health because it addresses NEI’s mission to eliminate vision loss and improve quality of life through vision research. The new and improved health information technology solutions proposed in this project can facilitate our understanding of the causes of health disparities in POAG and adopt strategies to enhance the model fairness for participants who are underrepresented in research, such as racial and ethnic minorities. The proposed research is also relevant to the NEI's strategic plan because it features NEI areas of emphasis that are dedicated to public health and health disparities research.